Computational de novo design of macrocyclic type I Signal Peptidase inhibitors

The emergence of antibiotic resistance poses a global medical threat. The discovery of new antibiotics from
naturally-occurring secondary metabolites or from high-throughput screening of chemical libraries has failed to
match the pace of resistance mechanisms. Therefore, new approaches for rapidly developing antibiotics are
required to address this global medical need. We propose to integrate computational peptide design, deep
learning, and high-throughput chemical synthesis to create a general framework for the structure-guided
design of new antibiotics. Our recent advances in physics-based and deep-learning-based peptide design
algorithms enable the design of structured peptide macrocycles with atomic-level accuracy. We will extend and
implement these computational methods to design inhibitors of a validated target for antibiotics — the bacterial
type I signal peptidase (SPase I). The secretion and correct folding of critical extracellular and periplasmic
proteins in gram-positive and gram-negative bacterial requires the cleavage of their preproteins by SPase I.
Naturally-occurring inhibitors of SPase I, arylomycins, show a limited spectrum of activity due to sequence
variations in SPase I from different pathogenic bacteria. We propose to implement parallel strategies to design
broad-spectrum inhibitors of SPase I. In one strategy, we will leverage the promising interactions between
arylomycin and conserved regions of the SPase I active site as starting points and extend these interactions
into macrocyclic inhibitors by sampling different backbone conformations and amino acid sequences inside the
SPase active site. In a parallel de novo design approach, we will first identify promising docked conformations
of individual amino acids to the SPase I pocket and then graft those interactions on pre-enumerated and
predesigned sets of millions of structured cyclic peptides. The de novo design approach will be more widely
applicable and enable targeting proteins that do not yet have a natural inhibitor identified. We will filter the tens
of millions of computational models in silico to find the best design models for experimental validation. The
promising design models will be chemically synthesized and screened for binding to SPase I as a massively
parallel macrocycle library with tens of thousands of members. We will further test the
computationally-designed macrocycles for SPase I binding, inhibition of the proteolytic activity, inhibition of
bacterial growth across multiple species, toxicity, and the accuracy of the designed binding mode. The overall
workflow will be implemented as iterative cycles of design-synthesis-test-learn to enable simultaneous
optimization of potency, bacterial growth inhibition, stability, and other drug-like properties. Overall, SPase I
inhibitors developed in this project will be promising candidates for further development as antibiotics. The
computational and experimental methods developed during this project will be broadly applicable to targeting
other bacterial proteins for designing new antibiotic candidates or inhibitors that can address antibiotic
resistance mechanisms.

Public health relevance
Methods for developing new antibiotics are urgently required to address the growing rise of antibiotic resistance mechanisms. We propose to leverage our recent advances in computational peptide design and integrate them with high-throughput chemical synthesis to develop inhibitors of a validated antimicrobial target – the type 1 bacterial signal peptidase. The computational and experimental methods developed in this project will be broadly applicable to developing superior analogs of naturally-occurring antibiotics and rationally designing new classes of antibiotics.